Dementia Risk Prediction Pooling Project

PROJECT SUMMARY
Alzheimer's Disease and related dementias (ADRD) are a major public health problem which is
increasing worldwide. Currently, over 5.8 million Americans are living with Alzheimer's or other dementias and
as our population continues to age this number will increase to over 13.8 million by 2050. Great strides are
being made in targeted therapies which may be able to reduce the risk for dementia. However, identifying
which patients should receive these prevention interventions is currently unknown and has been identified by
NINDS and experts in the field as a critical area of research. Research done by our group and others has
demonstrated that risk factor levels as early in life as the 20's influence an individual's future risk for dementia.
Early intervention to prevent the accumulation of risk and targeted interventions for those at high risk could
help to reduce dementia risk. Risk prediction methods can be used to accurately predict who is at high risk for
developing dementia and target interventions; however, current risk prediction models for dementia have
several critical limitations and none have taken into account longitudinal risk factor trajectories, a critical step to
implementing precision prevention approaches to identify individuals at high risk for dementia.
In this study we propose to develop the Dementia Risk Pooling Project (DRPP) by pooling and
rigorously harmonizing 12 prospective observational cohorts of middle and older age adults, multiple in-person
assessments of clinical, genetic and behavioral risk factors, follow-up of greater than 10 years and adjudicated
dementia ascertainment. The DRPP will be completed and made available to researchers via a cloud-based
computing platform as part of the R61 phase of this proposal meeting specific Go/No-Go Criteria outlined in the
grant. Then, within the R33 phase of this project we will use the DRPP to develop and validate an accurate
and personalized, dynamic dementia risk prediction model which incorporates longitudinal risk factor
measurements and easily updates as new measurements are accrued. This tool can be used clinically to
guide treatment decisions and will be made available to clinicians. The aims of this project are important and
timely, they will provide a risk stratification tool for targeted intervention/prevention for high risk individuals.

Public health relevance
PROJECT NARRATIVE Alzheimer's Disease and related dementias (ADRD) are a major public health problem. The Dementia Risk Pooling Project (DRPP) will pool and rigorously harmonize 11 prospective observational cohorts to develop an accurate and personalized, dynamic dementia risk prediction model to identify high risk individuals.